PHASE I STUDY OF ADOPTIVE CELLULAR THERAPY OF SOLID TUMOR MALIGNANCIES

To assess the feasibility, safety and toxicity of adoptive cellular therapy using three dose levels of tumorsensitized lymph node cells activated with Bryostatin, Lonomycin, and Interleukin-2 and expanded in low dose Interleukin 2